Re-Purposing of Metformin as a Countermeasure for Radiation-Combined Injuries

The changing geopolitical environment has increased the risk of mass population exposure to radiation, burn,
and trauma induced combined injuries that can result in chronic fibrosis from a large-scale radiological incident
improvised by a state or terrorist-owned nuclear device. There are a few countermeasures available that have
limited efficacy. The long-term goal is to develop a potent therapy for combined injuries and its addition to the
national stockpile. The overall objectives of this proposal are to (i) determine the dose of metformin that results
in the best mitigation from combined injury in animal models and (ii) test the titrated dose from the animal study
to mitigate combined injury in human skin tissue perfusion model and investigate the mechanism of metformin
action. The central hypothesis is that metformin-based topical ointment can mitigate combined injuries by locally
reducing cell damage, injury progression, and fibrosis by blocking TGFβ signaling. The rationale for this project
is that determining the mechanism of action and preclinical optimization of metformin topical therapy in relevant
preclinical animal and human tissue models offers a strong scientific framework for future clinical applications.
The central hypothesis will be tested by pursuing two specific aims: 1) titrate metformin concentration that
effectively mitigates combined injuries in animal models; 2) analyze the mitigation of metformin lotion for
combined injuries and underlying mechanisms in human full-thickness skin perfusion model. Under the first aim,
we will titrate the concentration of metformin in topical lotion efficacious to mitigate combined injury in mouse
models using clinically relevant functional, histological, and molecular read-outs. Our second aim will focus on
testing the best-mitigating dose from the animal studies in the human full-thickness perfusion model and
investigate the possible role of AMPK-mTOR-TGFβ axis in metformin-mediated mitigation by employing gain
and loss of gene function studies using pharmacological modulators of these pathways. The proposal is
innovative, as it aims to perform a pre-clinical evaluation and investigate the mechanism of action of a non-
invasive, off-the-shelf available therapeutic candidate cleared by the FDA for treating diabetes. The proposed
research is significant because the successful completion of this project will provide strong scientific justification
for starting a clinical trial as the next logical step in the therapy development process, FDA approval for use as
a combined injury mitigator, and addition to the national stockpile.

Public health relevance
Project Narrative The proposed research is relevant to public health because it will facilitate and vertically advance the development of critically needed medical countermeasures against combined (radiation, burn, and excision) skin injuries that are available off the shelf, can be easily stored and transported, and applied with minimal supervision within hours of mass population exposure. The proposed mechanistic studies will facilitate an understanding of the important factors involved in the mitigation process that can help in further improvement in the therapeutic approach. Thus, the proposed research is relevant to the NIH/NIAID/Radiation Countermeasure Program’s mission to develop new countermeasures and add them to the national stockpile.